Imaging Core

IMAGING CORE
SUMMARY
The Imaging Core provides CVS faculty with access to equipment and highly trained staff that
support histology, human and animal imaging, and adaptive optics for psychophysics and retinal
imaging. The Imaging Core is sub-divided into three facilities. The Histology/Microscopy
Facility supports brain and ocular tissue harvesting, processing, staining and microscopic
examination (qualitative and quantitative). It is staffed by Tracy Bubel with over 24 years of
experience in this area. The In Vivo Imaging Facility provides access to instruments for
anterior segment, retinal, and brain imaging in addition to functional assessments of vision. The
Adaptive Optics (AO) Facility consists of cutting-edge instrumentation utilising adaptive optics
for visual psychophysics and cellular-scale retinal imaging. The AO Facility is staffed by two
highly qualified engineers, Jie Zhang, Ph.D., and Qiang Yang, Ph.D. Through these three
Facilities, the Imaging Core meets the expanding imaging requirements for advanced vision
research and clinical research applications by CVS Core users.